Multiomics Core

PROJECT SUMMARY/ ABSTRACT
The Multiomics Core within the Hepatitis B HIV Cure Consortium (BICC) is committed to the development of
advanced tools and methods to better understand the complex interplay of Hepatitis B virus (HBV) genomic
diversity, the host immune response, and clinical outcomes among individuals co-infected with HIV. Central to
the core's mission are three primary objectives: Aim 1 focuses on refining single molecule DNA sequencing
techniques to better characterize HBV cccDNA and iDNA, even in low abundance samples. By adopting novel
amplification techniques and integrating epigenetic mapping strategies, this aim intends to unravel the
strategies HBV employs to circumvent immune detection, thereby highlighting potential therapeutic targets and
the mechanisms and structures critical for HBV's survival and replication. Aim 2 seeks to enhance single
molecule RNA sequencing protocols, focusing on improving efficiency and reducing costs. By leveraging
advanced cell sorting techniques along with more affordable reagents, this objective facilitates an efficient
comprehensive transcriptional profile of HBV-infected cells. Further, by incorporating single-cell proteomic
data, we aim to resolve a rich, detailed perspective of virus-cell interaction, which may uncover new
biomarkers or therapeutic targets. Aim 3 explores the application of graph-based bioinformatic methods to
capture intra-host quasispecies diversity and construct a detailed map of HBV genomic diversity across the
consortium's global cohorts. Exploration into phylogenetic methods leveraging genome graphs and recent
advancements in single molecule sequencing may produce more robust approaches for understanding
quasispecies diversity in relation to viral transmission dynamics, pathogenesis, treatment outcomes, and
mechanisms of immune escape. Through these objectives, the core seeks to develop novel tools and methods
that can advance our understanding into HBV, inform the development of targeted therapies, and ultimately
improve the management and outcomes for individuals co-infected with HBV and HIV.